A novel protective mechanism in hemorrhagic shock

Hemorrhagic shock in a major cause of death and disability both in the United State and globally. Patients who
survive the initial hemorrhage and trauma insult have poor functional outcomes and significantly increased long
term mortality. The management of rapid hemorrhage control is critical for improving survival in
shocked patient in surgery. Notably, systemic insulin resistance and metabolic disorders manifested as one of
the most common pathological processes in trauma and hemorrhage. The intervention for suppressing insulin
resistance and metabolic stress remarkably reduced the mortality of trauma and hemorrhage patients. Thus, the
strategy for controlling metabolic disturbances in hemorrhage and trauma has been recognized as one of the
most promising therapies in surgery. Skeletal muscle serves as an important secretory organ that secrete
numerous myokines, which have crucial roles in countering insulin resistance and metabolic disorders. Irisin, a
newly identified hormone, cleaved from Fibronectin type III domain containing 5 (FNDC5), is restrictedly secreted
from the skeletal muscle resource to regulate insulin sensitivity. Notably, the irisin receptor integrin V5 (IRRIV)
was recently identified to couple with irisin for eliciting a signaling pathway. Our exciting discovery has identified
irisin as having a key role in improving insulin sensitivity in skeletal cells via AMPK pathway. We have found that
hemorrhage resulted in a marked decrease in irisin and irisin receptor in skeletal muscle. Furthermore, a
profound impairment in systemic insulin resistance in hemorrhage was remarkably mitigated by irisin. Strikingly,
the deletion of irisin using CRISPR/Cas9 genome editing technology in vivo induced a profound insulin resistance
in the whole body. By using newly developed CRISPR/Cas9 genome editing technology, non-viral Gold-
nanoparticle delivery system, high throughput next generation sequencing, and large-scale assay of cytokines,
we will test our central hypothesis that irisin coupling with irisin receptor contributes critically to modulating insulin
resistance in hemorrhage at the genetic, cellular, and whole body levels. The proposed studies will be performed
based on the three specific aims. Specific Aim #1: Determine irisin/irisin receptor IRRIV modulation and their
impact on mitochondrial function in response to hemorrhage and trauma. Specific Aim #2: Determine the
functional role of irisin and irisin receptor in modulating systemic insulin resistance and metabolic disorder in
hemorrhage. Specific Aim #3: Determine whether irisin and irisin receptor IRRIV mediate hemorrhage-induced
cardiac depression, inflammatory cytokines and ultrastructural damage. Taken together, the proposed studies
will for the first time define the crucial function of the irisin/irisin receptor in mediating insulin resistance and
metabolic disorders in hemorrhage. The proposal uncovers novel insight into understanding the mechanism of
hemorrhage in the field. More importantly, investigation of the functional role of irisin/irisin receptor holds promise
in developing an entirely new therapy in hemorrhage and surgical therapy.

Public health relevance
This project not only advances our understanding of the novel working module by which irisin/irisin receptor mediate hemorrhage and trauma associated with a systemic metabolic response, but also holds promise to developing a new therapeutic strategy for hemorrhage, trauma, systemic metabolic disorder, and multiple organ failure in surgical therapy.